Molecular Regulation of Breast Cancer Progression

Background: Cancer of the breast (BrCa) is the most frequent tumor in women, affecting black women most
severely; BrCa is also more prevalent and morbid in military women. Localized primary carcinomas are often
found and removed, curing up to 80% of the women and few men afflicted. Once the cancer has disseminated,
current therapies, even newer biologics and immunotherapies, prolong life for just a few years. Signals and cell
behaviors that enable metastatic survival and outgrowth of disseminated tumors are critical transition points.
Our investigations during the present and previous Award periods demonstrated that upon dissemination to
the ectopic microenvironment, the parenchymal cells direct the tumor cells to re-express epithelial markers
including the defining E-cadherin. This cell-cell cohesion marker forms heterotypic binding that renders the
tumor cells more resistant to killing by chemotherapies and death cytokines and down-regulate targets of
immunotherapy. This protection from death signals proceeds through E-cadherin-triggered signaling involving
at least the PI3 kinase-AKT pathway with the specific pathways being targeted herein.
We also investigate that this epithelial reversion also likely leads to tumor cell dormancy, a complication of
tumor dissemination. We have modeled this to demonstrate that quiescence of the entire organ underlies the
dormancy, but that this non-proliferative state is plastic with stimulated cells being `awakened' and regaining an
aggressive mesenchymal phenotype secondary to activation of the supporting nonparenchymal cells by
specific stressors leads to inflammation-triggered outgrowth that will be investigated herein.
Hypothesis: Our foundational model posits that E-cadherin-ligandation signals promote tumor cell dormancy
and survival via select signaling pathways that can be targeted to reverse the chemo-resistance and possibly
immune-escape. By discerning the operative signals and pathways we can develop novel approaches to
micrometastases in targeting the emergent breast cancer cells. The interplay of tumor cells with cells of the
metastatic microenvironment dictates both responsiveness to tumor-targeted therapies and dormancy/
outgrowth. This hypothesis leads to two linked questions – what are the mechanisms that confer the resistance
of metastasis, and why do the tumor cells then later emerge from this dormant stage to grow as lethal tumors.
These topics will lead to novel approaches by which these emergent carcinoma cells will be targeted.
Specific Aims: Two linked but independent aims will be pursued simultaneously:
I. Define the key tumor cell mechanisms that provide for resistance to killing in the micrometastatic
niche and determine if targeting them can enhance chemosensitivity. E-cadherin promotes survival, at
least in part, by signaling via the canonical AKT pathway, with our preliminary data supporting that targeting
these intermediary kinases can abrogate the chemoresistance of metastasis. However, different AKT isoforms
confound the efficacy. Enhanced chemo-sensitization will be established in a combination of preclinical models
in culture, and innovative ex vivo microphysiological systems/bioreactor, and then validated in animal models.
II. Determine the cues that activate the micrometastatic niche to trigger emergence from dormancy.
Emergence from dormancy heralds the lethal stage of disseminated breast cancer. We found that the micro-
metastatic niche both reflects and supports the quiescent during dormancy and activation driving outgrowth.
We will determine critical signals in inflammatory response/tumor growth event for biomarker development and
intervention using patient-derived tumor cells and serum specimens, validating in preclinical models.
The successful completion of these experiments will shed new light on how to manipulate molecular controls
of cell behavior that are subverted in breast carcinoma to promote progression. Validation of even components
of our foundational model and our initial translational effort would highlight future avenues for rational
interventions for the therapeutically refractory stage of cancer, clinically undetectable micrometastases.

Public health relevance
Breast cancer plagues military women (and even men) to a greater degree than the civilian population, and women of color also more severely. Breast cancer in military and veteran women is so devastating that a number of bills have been forwarded to directly address this occurrence. Our proposal will focus on the metastatic disease that directly leads to mortality. Our VA Merit program has found that disseminated disease is resistant to current therapies as the local micro-environment provides signals that protect the tumor cells. Herein we will discern those signals, to development biomarkers for detecting cryptic disease, and disrupt the key ones to restore responsiveness to current and emerging therapies, including immunotherapies. Even partial support of our hypothesis would suggest new diagnostic and therapeutic approaches to disseminated cancer, and novel insights to treat cryptic disseminated disease even attacking dormant cells. Longer term, new targets would be defined so as to render these metastases sensitive to agents for curative effect.